Genetic determinants of Acinetobacter baumannii desiccation tolerance

DESCRIPTION (provided by applicant): Nosocomial infections are an important healthcare and economic burden in the United States. Their prevention is therefore important for decreasing patient morbidity and mortality and overall financial costs. Acinetobacter baumannii is a Gram-negative opportunistic pathogen and one of the most common causes of nosocomial infections worldwide. It frequently causes ventilator-associated pneumonia and septicemia and has become a particular problem in soldiers returning from Iraq and Afghanistan with wound injuries. High antibiotic resistance levels hinder treatment of these infections. Compared to other Gram-negative bacteria, A. baumannii is highly desiccation tolerant. This phenotype plays a major role in its transmission because patients and healthcare workers come into contact with contaminated surfaces and medical devices. Currently, the genetic mechanisms mediating desiccation tolerance in A. baumannii are unknown. The overall goal of this project is to identify and characterize factors that contribute to desiccation tolerance in A. baumannii. Since desiccation tolerance is a complex trait, I hypothesize that A. baumannii utilizes both conserved and novel mechanisms to tolerate water loss. The results generated from these studies may lead to new strategies for preventing and containing A. baumannii infections.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Gram-negative bacterium Acinetobacter baumannii is one of the most frequent causes of hospital- acquired respiratory, blood, burn, and wound infections. This proposal uses genetic and biochemical techniques to identify and characterize genes involved in A. baumannii desiccation tolerance. This phenotype plays a major role in A. baumannii transmission via contaminated surfaces and healthcare workers' hands. The results from these studies will provide a basic understanding of this pathogen's environmental lifestyle and may lead to new strategies for preventing and containing infections.